Mechanisms Contributing to Functional Recovery across the Care Cascade for Respiratory Failure

PROJECT SUMMARY
Respiratory failure is a life-threatening condition affecting millions of individuals in the United States annually.
Although mortality rates for respiratory failure have decreased, survivors frequently experience persistent
physical impairments and decreased quality of life. Little is known about how factors experienced across the
course of critical illness, such as receipt of specific care processes (e.g., early mobilization) or post-discharge
setting (e.g., neighborhood environment) influence functional recovery and quality of life. To identify targets for
intervention on disparities in recovery from respiratory failure, it is critical to examine the sequential impact of
social determinants before hospitalization, care processes during hospitalization, and living environments
following hospitalization. The goal of the proposed research is to generate evidence to inform interventions
promoting recovery of function following hospitalization with respiratory failure. The central hypothesis of this
proposal is that patient-level social determinants, unit-level care processes, and community-level
environmental factors produce disparities in long-term outcomes among survivors of respiratory failure.
In this research, the applicant aims to: 1) examine the influence of social determinants recorded at hospital
admission on functional recovery over time among survivors of respiratory insufficiency and failure; 2)
characterize the barriers to providing early mobilization in two high-volume medical intensive care units
(MICU); and 3) evaluate the influence of neighborhood environments on long-term recovery among survivors
of respiratory failure. The proposed research will take place at New York University (NYU), which provides a
robust research infrastructure that supports proposal development and fosters research engagement among
NYU faculty and students.
Training goals throughout the fellowship award include (1) build advanced methodological skills in state-of-
the-art longitudinal modeling techniques applied to complex real-word data; (2) advance capabilities in
qualitative data collection and analysis using gold-standard methods from the social sciences and
implementation science; (3) develop analytical skills in Bayesian analysis; (4) develop a comprehensive
knowledge of key theories, frameworks, and concepts that explain health disparities; (5) strengthen skills in
scientific writing and dissemination; and (6) study and practice the responsible conduct of research. Mentorship
and supervision from Sponsor, Co-Sponsors, and Contributor will occur regularly throughout the fellowship
award to augment all aspects of training. The F31 will also provide crucial protected time to advance toward
the goal of a productive career as an independent research career as an epidemiologist of function.

Public health relevance
PROJECT NARRATIVE Respiratory failure is a serious condition affecting millions of individuals in the United States annually. Survivors are left with functional deficits, such as difficulty bathing, toileting, or walking, that can persist for years. Understanding patterns in functional recovery and delivery of the care processes that can improve recovery is critical to improving health outcomes for survivors of respiratory failure.